Mapping Tight Junction Architecture

Project Summary
Endothelia and epithelia throughout the body rely on macromolecular complexes known as tight junctions to
modulate tissue barrier selectivity, proliferation, and polarity. Tight junctions are intercellular adhesion
complexes that form strands around the apical side of cell-cell junctions. Tight junctions act as barriers that
protect organs from pathogens while simultaneously allowing for the selective passage of nutrients, which
establishes the chemical microenvironments of all tissue compartments. Thus, tight junction dysregulation is a
hallmark of many human diseases. According to prevailing models, tight junctions assemble around oligomeric
strands of claudin integral membrane proteins. The properties and stoichiometry of these strands are then
augmented by the integral membrane protein occludin and the peripheral membrane protein ZO-1. To date, no
direct observation of the interaction of tight junction subunits has been observed to support these models. This
is a major gap in our understanding of how the chemical microenvironments in all tissue systems are
established, and a roadblock in therapeutic intervention. In this proposal, using an approach integrating
structural biology, cell biology, and physiology, we will uncover the structural determinants of tight junction
function through elucidating the mechanisms of claudin oligomerization, claudin barrier function, and how tight
junction subunits assemble with claudins to tune tight junction function.

Public health relevance
Project Narrative Tight junctions are macromolecular complexes found in endothelia and epithelia that are vital to the maintenance of tissue homeostasis. Tight junction assemblies must simultaneously allow passage of nutrients while maintaining cell-cell adhesion and preventing passage of pathogens. The structural basis of this tight junction function is unknown and prevents medical advancement in a wide range of diseases.